Inhibition of viral membrane fusion by interferon-induced proteins

Interferon-induced transmembrane proteins (IFITMs) inhibit fusion of diverse enveloped viruses with host cells
through a poorly understood mechanism. At least two modes of restriction have been described for IFITMs –
protection from incoming viruses when expressed in target cells and reduction of infectivity of progeny virions
upon incorporation into the viral membrane (dubbed “negative imprinting”). According to the currently accepted
“tough membrane” model, IFITMs block viral fusion by increasing the negative curvature, lipid order and bending
modulus of cell membranes and, thereby, arresting fusion at a hemifusion stage. However, our pilot results
challenge this model by revealing that, whereas IFITM expression in cells increases the lipid order of intracellular
compartments, the membrane of HIV-1 particles produced by IFITM-expressing cells has lower lipid order and
membrane tension. Another critical new finding is that IFITM mutants that lack antiviral activity when expressed
in target cells incorporate into and negatively imprint progeny virions. These results highlight key differences
between the effects of IFITMs on cellular vs viral membranes and warrant further investigation. Our central
hypothesis is that IFITMs inhibit viral entry through a multifaceted mechanism that involves: (a) rigidification of
cell membranes at the sites of virus entry that arrests fusion at a hemifusion stage; and (b) “negative imprinting”
of virions through reducing the order and tension of viral membrane and/or disrupting its nanoscale organization.
To test this hypothesis, we propose the following Specific Aims. Specific Aim 1 will focus on ultrastructural basis
for IFITM-mediated inhibition of viral fusion with endosomes, using correlative light-electron microscopy, electron
tomography, and immunogold EM to elucidate the primary mechanism of the influenza A virus restriction by
IFITM3 and the mechanism of fusion rescue by cyclosporine A treatment. Specific Aim 2 will define the
determinants of stability of IFITM-arrested hemifusion intermediate through experimental manipulations that alter
the propensity of arrested hemifusion to progress to full fusion. Specific Aim 3 will identify the IFITM residues
that are critical for negative imprinting of virions, which are distinct from residues regulating the protection of
target cells from infection; this will be accomplished by constructing and testing chimeras between active and
inactive IFITM orthologs. Specific Aim 4 will delineate the effects of IFITMs on viral membrane in the context of
negative imprinting of virions, which we hypothesize to occur through disruption of nanoscale organization of
viral membrane and/or reduction of viral membrane tension. Successful completion of these Specific Aims will
provide critical paradigm-shifting insights into the mechanism(s) of antiviral activity of IFITMs expressed in target
cells and incorporated into progeny virions.

Public health relevance
Interferon-induced transmembrane proteins (IFITMs) inhibit entry of diverse enveloped viruses upon expression in target cells and upon incorporation into progeny virions. While rigidification of cell membranes (“tough membrane” model) has been widely accepted as the universal mechanism for IFITMs' antiviral activity, our results challenge this hypothesis and support a multi-faceted model instead. We will apply innovative imaging and biophysical approaches to elucidate the mechanistic differences between the two modes of virus restriction by IFITMs.